MULTIPLE DOSES OF INTRAVENOUS RHU-IL10 (SCH 52000) IN CROHN'S DISEASE

This trial is a multi-center, randomized, double-blind placebo controlled, rising, multiple dose, safety and tolerance study whose objective is to evaluate the safety and tolerance of multiple doses of intravenous (IV) SCH 52000 in patients with steriod rafractory Chron's disease.